Comprehensive Mechanisms in Reproductive Sciences

Project Summary and Abstract
Our program goal is to train talented young scientists for research-intensive and research-related careers
in reproductive biology. Baylor College of Medicine is a long-standing leader in reproductive biology research.
Predoctoral and postdoctoral trainees receive mentored training in biomedical research and career development
to obtain skills necessary for a variety of career paths. The predoctoral program combines state-of-the-art training
in premier reproductive biology laboratories along with didactic learning. Postdoctoral fellows attend courses and
seminars alongside their research training. Both will have structured committees for research and career advising
that include a formal oral presentation. Trainee mentorship is guided by program-specific Individual Development
Plans (IDP), developed in conjunction with the mentor and a core executive committee member. Activities to
enhance skills in teaching, clinical/translational work, and entrepreneurship, is offered by BCM and neighboring
collaborative institutions within the world's largest medical center. Program specific activities include a mentored
journal club, an annual mini-symposium, research advisory committees, NRMN modules for mentor-mentee
training, formal critiques of oral communications, assistance with development of fellowship applications, and
individual career planning programs. These programs are supplemented with training in responsible conduct of
research and a novel “ethics in reproductive health learning unit” specifically designed for this proposal. The 13
faculty members have been selected for contemporary research interests in reproductive biology and are
currently supported by over $14 million in funding with $6 million in NICHD funding alone (43% of total PI
funding). Their research areas fall squarely within the mission of NICHD, and includes studies of key reproductive
biology proteins, normal and pathophysiology of male and female reproductive tissues, genetic and
environmental factors that affect fertility, and translational research (male contraceptive development and
developmental origins of adult disease). The training faculty use cutting edge approaches to study reproductive
processes using genetic models, patient samples, in vitro models, and clinical data. Our program is designed for
three predoctoral students and four postdoctoral fellows. We plan to support trainees for two years with an option
to compete for a third year. Due to the long-standing reproductive biology research program at BCM and an
active national recruiting strategy, we currently have a strong applicant pool in our training labs from which to
select trainees, including pre- and postdoctoral trainees from UR groups. In total, our program provides
necessary skills and experience to prepare the next generation of scientists for successful and diverse careers
in reproductive biology.

Public health relevance
Project Narrative Reproductive disorders as well as contraception/family planning have major impacts on the health and well being of individuals and their children worldwide. This training program prepares young scientists to address these important problems at the level of basic and translational research and in research-related careers that require expertise in reproductive biology.